Comparative Single Cell Profiling of Retinal Development

Project Summary
Age-related macular degeneration (AMD) affects the central region of the retina important for high-acuity
daytime vision, causing blindness or severe vision impairment as a result of the loss of photoreceptors from the
cone-dominant fovea. Directed differentiation of retinal progenitor cells into cone photoreceptors shows
promise as a therapy for AMD and other retinal dystrophies. However, commonly used model organisms such
as the mouse have rod-dominant retinas, which makes them poor models for the human fovea. 13-lined
ground squirrel retinas, however, have a cone/rod ratio and cone subtype composition that closely matches
that of the human fovea. This project will use the 13-lined ground squirrel as a model to identify gene
regulatory networks that drive development of retinal cones and test whether gain of function of candidate
genes can promote cone development in mice. I hypothesize that differential activation of gene regulatory
networks controlling photoreceptor development underlie the differences in the cone/rod ratio between
the mouse and 13-lined ground squirrel and between the peripheral human retina and the cone-
dominant fovea. To address this hypothesis, I propose two Aims. Aim 1: Comprehensively profile retinal
development in the 13-lined ground squirrel at single-cell resolution using both scRNA-seq and scATAC-seq to
identify candidate gene regulatory networks that control evolutionary changes in the cone/rod photoreceptor
ratio. This data will allow me to identify key gene regulatory networks that control development of the 13-lined
ground squirrel retina and will identify plausible causes for the difference in the production of photoreceptor
subtypes between 13-lined ground squirrel and mouse and between the fovea and peripheral human retina.
Aim 2: Test the functional consequences of overexpression of candidate genes in mice that are predicted to
promote cone specification in 13-LGS. This will identify which changes are necessary to control the cone/rod
ratio in the developing mouse retina. By understanding the gene regulatory networks that control photoreceptor
proportions in the retina, I will be able to direct mouse retinal progenitors to generate a cone-dominant retina,
ultimately providing an improved animal model for AMD progression and cell therapy.

Public health relevance
Project Narrative I will profile gene expression and chromatin accessibility in the cone-dominant developing retinas of 13-lined ground squirrels at single-cell resolution and compare these data to results previously obtained from the rod- dominant mouse retina. Candidate regulators of cone photoreceptor development will then be functionally investigated in developing mice. This will ultimately help identify gene regulatory networks that can be used to create a cone-dominant mouse model and promote the directed differentiation of iPS-derived human cones for use in cell-based therapies for photoreceptor dystrophies.